Kinesin Force Production and Biomechanics of Division

Abstract
During division, chromosomes segregate on the spindle, a large array of overlapping, crosslinked microtubules
that transduces mechanical forces. The forces are thought to be produced primarily by motor proteins and
microtubule dynamics – rapid microtubule growth and shrinking. Despite decades of work on motors and more
than a century of work on division, the motor mechanism is still not fully understood and the critical load-
bearing elements of the spindle have not been identified. The molecules involved in bearing loads in the
spindle are probably motors and other spindle proteins, but the forces across these molecules have not been
probed – how the forces change spatially and temporally during division is not known. The proposed studies
will begin to fill this gap by identifying the force-producing spring-like element of the kinesin motors and by
measuring loads across a motor protein in the spindle. Kinesin-14 Ncd is essential for division in Drosophila –
the motor produces force to slide microtubules and resists forces through its crosslinking activity. New Ncd
mutants will be designed and tested, and structural changes that decouple the motor mechanical and chemical
cycles, altering motor mechanical output, will be analyzed. New TsNcd FRET tension sensors have been
created and will be assayed in mitotic spindles to measure loads borne by Ncd during mitosis and determine
effects of uncoupling mutants and mutants that affect other spindle proteins. The proposed studies will yield
information about the structural changes in the kinesin motors that produce force, the loads borne by a motor
in the spindle, and how changes in force and microtubule crosslinking produced by the motor affect the loads.
We will test the hypothesis that the Ncd motor produces tension in spindles primarily by crosslinking
microtubules, mechanically resisting oppositely-directed sliding forces, rather than by its minus-end motility.
Specific aims are to 1) Identify the spring-like element of the kinesins essential for force production by
testing the hypothesis that bending or distortion of the central ß-sheet stores and releases free energy during
the mechanochemical cycle, functioning as the elusive spring-like element of the motor, and 2) Measure
motor loads in spindles due to force production and resistance to other forces using new TsNcd tension
sensors created from the kinesin-14 Ncd motor and a previously reported FRET tension sensor, and by
assaying mutants that increase Ncd crosslinking or both crosslinking and sliding. Mutants in other spindle
proteins, including oppositely-directed motors, will be tested to identify other load-bearing spindle molecules.
These studies will provide new information about how kinesin motors produce force and contribute to
mechanical forces in the mitotic spindle, preventing division errors that lead to birth defects.

Public health relevance
Project Narrative There is currently a critical gap in our knowledge about how motors produce force and contribute to forces in the spindle during mitosis, including the load-bearing elements of the spindle, the molecules that are involved, and the changes in load during mitotic progression. The proposed studies will begin to fill this gap by producing new information about the forces in the spindle that are required for normal division and the disruptions that lead to division errors and birth defects.